Administrative Core (Core A)

Abstract
The purpose of the Administrative Core (Core A) is to provide key administrative and organizational support
that will enable the Project Leaders, their staff and the Animal and Microsurgery Core (Core B) to focus on their
experimental and scientific efforts. The specific tasks of Core A will be to: a) facilitate interactions between
Program investigators, Scientific Advisors/Consultants and administrative personnel; b) plan and coordinate
the meetings between the Project Leaders and their staff; c) plan and coordinate travel for the external scientific
advisory committee members, the Project Leaders and their professional staff; d) assist in assembling and
maintaining the timely submission of multi-user and individual Institutional Animal Care and Use Committee
(IACUC) protocols that cover the efforts included within this program; e) assist in assembling and maintaining
the timely submission of Institutional Animal Biosafety Committee (IBC) protocols that cover the use of select
agents included within this program; f) facilitate resource sharing among the Project Leaders; and g) assist the
Project Leaders in the preparation of progress reports, financial reports and manuscripts for publication.

Public health relevance
Transplantation tolerance, a state of immune hyporesponsiveness to a graft following cessation of immunosuppressive therapy, can prevent complications from life-long global immunosuppression but is rarely attained in the clinic. This PPG addresses the barriers to both the induction and long-term maintenance of transplantation tolerance, and explores two potential solutions that leverages the natural ability of pregnancy to tolerize fetus-reactive T cells and harnesses the capacity of chronic antigen exposure to drive immune hypofunction.